Unique Considerations in the Older Patient Considering Surgical Management of Primary Hyperparathyroidism

Project Summary/Abstract
Primary hyperparathyroidism (PHPT) is a calcium metabolic disorder affecting nearly three million
Americans, with a significant predominance in older adults. If left untreated, PHPT can lead to serious
health complications, including fractures, neurocognitive decline, kidney stones, and kidney failure.
While surgical parathyroidectomy (PTX) provides the only definitive cure, it remains underutilized,
disproportionately so among the geriatric population. Various factors contribute to this underutilization
of PTX in the geriatric population, including both perceived and actual risks of perioperative
complications in older patients, competing medical priorities, under-recognition of the condition, and
limited access to care. Current understanding of the risks associated with PTX in this demographic is
superficial, lacking depth regarding the influence of frailty status and the unique priorities of older
patients and their care teams in the decision-making process surrounding PTX. A critical barrier to
enhancing surgical decision making for older patients with PHPT lies in the absence of detailed,
personalized predictions of perioperative complications, as well as a lack of insight into the
specific priorities of older patients and their healthcare providers. The overall objective of this
proposed study is to improve surgical decision-making for older patients with PHPT through the
development of personalized predictive models for PTX-related complications and by exploring the
unique priorities and values that shape both patient and provider decision making. To achieve these
objectives, two specific aims are outlined: 1) Develop predictive models for PTX-associated
complications, leveraging age, frailty status, and relevant clinical characteristics within a large national
cohort, and validate the models externally; and 2) Evaluate the unique priorities that influence older
patients and their care teams when considering surgical management for PHPT. This research will yield
validated models for predicting PTX-associated complications in older patients and will identify barriers
and facilitators influencing surgical decision-making in this population, providing critical insights into the
roles of patient and provider priorities and values. Ultimately, this work will enhance the alignment of
care with the preferences and needs of older patients with PHPT, facilitating better health outcomes
and more appropriate provision of care.

Public health relevance
Project Narrative Primary hyperparathyroidism (PHPT) is a disorder affecting millions of older adults and can lead to fractures, cognitive decline, and renal failure, all exacerbated in older age. Although parathyroidectomy is the only definitive treatment, a minority of eligible patients undergo surgery due to concerns about complications and limited understanding of the risks for older adults. This project aims to develop complication prediction models and assess patient and provider decision-making priorities, ultimately supporting more informed, personalized surgical decisions for older patients with PHPT.